Patient Oriented Research and Mentorship in Childhood Obesity Disparities

Project Abstract
Childhood obesity represents a substantial burden on morbidity and is a major risk factor for cardiovascular
disease. Racial and ethnic minorities and children from disadvantaged backgrounds suffer a disproportionate
share of the national obesity burden. Despite availability of proven-effective interventions for childhood obesity
management, effective interventions are underutilized and there remains a substantial gap in the adoption of
evidence-based practices in settings that care for low-income children and populations with high burden of
social risk factors. This K24 renewal application will support equity-focused implementation research to
improve the adoption of effective childhood obesity interventions among clinicians and families and reduce
obesity disparities among low-income, racial/ethnic minority children. This application will take advantage of a
newly-funded, NHLBI R01 implementation research grant to optimize integration of the Connect for Health
pediatric weight management intervention in pediatric primary care settings. With NHLBI funding, we are
testing key adaptations and strategies that will support the implementation of Connect for Health across health
care systems in Massachusetts that deliver care to low-income children. K24 funding will allow the PI and her
mentees to extend and amplify the NHLBI study by examining a new adaptation: use of social- and
neighborhood risk-informed obesity care plans to increase the effects of childhood obesity interventions on
obesity outcomes. The overall goals of this K24 renewal application are to provide Elsie Taveras MD, MPH
with protected time to serve as a mentor to junior clinical investigators in their progress toward becoming
independent patient-oriented investigators, and to support new scientific aims that will build upon Dr. Taveras’s
established work on childhood obesity, health disparities, and equity-focused implementation science. Dr.
Taveras is Professor of Pediatrics and Nutrition at Harvard Medical School and Harvard T.H. Chan School of
Public Health, and a pediatric obesity specialist at Massachusetts General Hospital for Children. She leads
several large patient-oriented research studies including a NHLBI-funded implementation study that will serve
as the basis for her proposed aims. Dr. Taveras has already successfully served as a research mentor to more
than 40 MD and PhD candidates and clinicians in training. Her original K24 focused on understanding the
contextual roots of childhood obesity disparities and developing interventions to prevent and manage obesity.
This K24 renewal award is a natural extension of this work and will shift focus to translational studies and
implementation science. The K24 renewal will heighten Dr. Taveras’s research productivity in the area of
childhood obesity disparities and help foster the careers of junior childhood obesity scientists through her
mentorship. The proposed scientific aims of this K24 application will serve to strengthen Dr. Taveras’s ability to
provide mentorship to junior investigators in patient-oriented research, with an emphasis on equity-focused
implementation research to improve adoption and effects of childhood obesity interventions.

Public health relevance
Project Narrative Substantial disparities exist in childhood obesity and cardiovascular disease among racial and ethnic minorities and children from disadvantaged backgrounds. Despite availability of proven-effective interventions that aim to improve childhood obesity, substantial gaps remain in the adoption of recommended practices, particularly in settings that care for low-income children. The overall goals of this K24 application are to provide Dr. Elsie Taveras with protected time to perform equity-focused implementation research to accelerate the adoption of effective interventions to reduce childhood obesity and to train students, fellows, and junior faculty who wish to perform patient-oriented outcomes research in childhood obesity disparities.